SPORE in Breast Cancer

PROJECT SUMMARY/ABSTRACT: OVERALL
Using the well-established framework of a very active and strong multidisciplinary Vanderbilt-Ingram Cancer
Center (VICC) Breast Cancer Program that is robustly supported by the SPORE mechanism, we have made
significant progress in our current project period. With supplemental funding, our overall goal remains the
same: To conduct collaborative, multidisciplinary and mechanism-based translational research that will have
the highest possible impact on women and men with or at risk for breast cancer. After planning and internal
and external advisory board evaluation, we propose to continue our research on three translational projects,
primarily targeting triple-negative breast cancer, with integrated guidance from patient advocates, to ensure
that we are inclusive of the patient perspective in meeting our goals. The projects are as follows: Project 2 -
Strategies to Improve Outcomes for TNBC Patients Integrating Subtype-specific Genomic and Immune-based
Discoveries; Project 4 - Targeting Antigen Presentation to Improve Immunotherapy Responses in Breast
Cancer; and Project 5 – Liquid Biopsies to Guide Therapies in Triple-Negative Breast Cancers. The projects
require three highly integrated shared core resources: Administration and Engagement, Biostatistics and
Bioinformatics, and Pathology and Tissue Informatics. The cores bring innovative technology, resources, and
personnel with project-specific expertise to the overall VICC Breast SPORE Program and do not duplicate pre-
existing shared resources available at VICC or Vanderbilt University Medical Center (VUMC). We have an
expert multidisciplinary team that will accomplish the proposed aims and continue to have productive
translational collaborations with other Breast Cancer Programs, SPOREs, and national and international
groups.

Public health relevance
PROJECT NARRATIVE: OVERALL The Vanderbilt-Ingram Cancer Center SPORE in Breast Cancer has made notable advancements across the spectrum of breast cancer research. With supplemental funding, our primary objective is to conduct collaborative and impactful translational research for those affected by or at risk of breast cancer. We propose to further our research on three translational projects, primarily targeting triple-negative breast cancer, with essential support from three cores: Pathology and Tissue Informatics, Biostatistics and Bioinformatics and Administrative and Engagement; and patient advocates, to ensure that we are inclusive of the patient perspective in meeting our goals.